TARGETING INSULIN RESISTANCE TO IMPROVE ABNORMAL CARDIOVASCULAR CONTROL IN DIABETES

Project Summary/Abstract
In patients with type 2 diabetes mellitus (T2DM), exercise elicits an excessive increase in blood pressure (BP).
Since such an exaggerated BP response to physical exertion increases the risk for the development of an
unfavorable cardiovascular event, elucidating the mechanisms responsible is clinically important. The exercise
pressor reflex (EPR, a reflex originating in skeletal muscle) plays a pivotal role in regulating the cardiovascular
system during exercise. Sensory signals from exercising muscle are generated by activation of mechanically
sensitive (muscle mechanoreflex) and chemically sensitive (muscle metaboreflex) afferent neurons. Although it
has been shown that muscle metaboreflex function is augmented in T2DM patients, it remains to be elucidated
whether the muscle mechanoreflex is altered as well. Chronic hyperinsulinemia associated with peripheral
insulin resistance is one of the pathophysiological characteristics of T2DM. Insulin directly influences the
nociceptive ion channel function of the transient receptor potential vanilloid receptor 1 (TRPV1) in muscle
known to contribute significantly to metaboreflex function, suggesting that hyperinsulinemia may peripherally
augment EPR function in T2DM. In contrast, chronic hyperinsulinemia results in impairment of insulin transport
to the central nervous system, decreasing the activity of the insulin signaling pathway in the brain. Thus,
peripheral and central changes in insulin handling may contribute to the generation of abnormal EPR activity in
T2DM. The global objective of this proposal is to determine the mechanisms underlying the heightened BP
response to exercise in T2DM. We hypothesize that alterations in muscle mechanoreflex and metaboreflex
function significantly contribute to the evolution of abnormal circulatory control in T2DM and that central as well
as peripheral insulin resistance potentiates EPR activity in T2DM. We further hypothesize that the enhanced
BP response to exercise in T2DM is ameliorated by blocking chemically sensitive muscle receptors
peripherally or increasing the delivery of insulin centrally. Therefore, we propose in vivo and in vitro studies in
diabetic animals to integratively determine: a) whether the heightened exercise BP in T2DM is mediated by an
overactive muscle mechanoreflex as well as metaboreflex (specific aim 1); b) whether peripheral insulin
resistance leading to muscle hyperinsulinemia contributes to the exaggerated EPR in T2DM which can be
ameliorated by antagonizing TRPV1 and mechanically sensitive receptors (specific aim 2); and c) whether
central insulin resistance leading to brain hypoinsulinemia contributes to the exaggerated EPR in T2DM which
can be ameliorated by increasing central delivery of insulin (specific aim 3). The proposed studies are
innovative in that they maintain the potential to shift current clinical practice paradigms by identifying insulin
resistance as a key target for the prevention and treatment of abnormal cardiovascular control in diabetes.
Ultimately, the results of our work could lead to more effective strategies for reducing the global burden of
diabetes-associated cardiovascular disease.

Public health relevance
Project Narrative Insulin resistance is one of the pathophysiological characteristics of type 2 diabetes, thereby sensitizing skeletal muscle sensory neurons that contribute to increasing blood pressure during exercise and impairing insulin transport to the central nervous system decrease the activity of the insulin signaling pathway in the brain potentiating the blood pressure response to exercise. The current proposal aims to examine the mechanisms of peripheral and central insulin resistance that induce abnormal autonomic cardiovascular control in type 2 diabetes. Identifying potential treatments that could improve abnormally high exercise blood pressure responses in type 2 diabetes may allow the safe prescription of physical activity as a beneficial therapeutic intervention in this disease.